Transactional Success in the Texting Exchanges of People with Aphasia

Abstract
Individuals with aphasia experience reduced social networks, a contributor to poor health-related quality of life.
Increased reliance on electronic communication in today’s digital world may exacerbate the challenges
individuals with aphasia have in connecting with others and accomplishing their participation goals. Indeed,
preliminary research shows that people with chronic aphasia have fewer contacts with whom they text and
fewer text exchanges than neurologically healthy adults. The long-term goal of the proposed research is to
develop an intervention to support electronic messaging in individuals with aphasia to provide access to a
mode of communication that is critical for maintaining and strengthening relationships. The overall objectives of
this proposal are to: 1) validate a novel measure of transactional success (information exchange) in texting and
2) identify texting behaviors that persons with aphasia and their partners engage in that enable and detract
from texting success. The rationale for this proposal is two-fold. First, it is critical to have a psychometrically
strong measure to assess texting performance in persons with aphasia. Second, it is imperative to identify
factors associated with successful transaction to develop an intervention that facilitates texting. To attain the
overall objective, the following specific aims will be pursued via a mixed methods approach. Aim 1 uses a set
of statistical analyses to evaluate the validity and reliability of a measure of texting transactional success
(TTS). The psychometric properties of a TTS rating scale will be evaluated using performance data from 60
participants with chronic aphasia on a three-turn texting script collected under a previous clinical trial. Aim 2
applies the TTS scale to authentic texting data collected from a prospective sample of 24 individuals with
aphasia. External validity of the standard texting script will be assessed by examining the agreement between
participants’ scores on this measure and scores yielded from participants’ authentic text exchanges. Aim 3
identifies texting behaviors used by people with aphasia and their partners that enable and disrupt
transactional success. Conversation analysis will be employed to text exchanges from the same sample of
participants from Aim 2 to reveal repair strategies and various multimedia and paralinguistic tools (e.g. emojis,
images, CAPS, punctuation) that may enhance transactional success. These repair behaviors and
multimedia/paralinguistic tools are strategies that could be trained to increase texting success. The proposed
research is innovative because it addresses texting, an increasingly pervasive mode of communication that is
understudied in aphasia rehabilitation. This research applies conversation analysis to study text messaging in
aphasia, a novel application of this methodology. The proposed research is significant because the contribution
of a validated measure of TTS will offer a means of assessing texting performance and evaluating treatment
outcomes. Findings will inform future development of an intervention to support texting in people with aphasia
and potentially reduce social isolation and improve quality of life.

Public health relevance
Project Narrative The proposed research investigates transactional success in the texting exchanges of people with aphasia, many of whom experience reduced social networks and health-related quality of life. Findings will contribute to future development and evaluation of a novel intervention to support texting in people with aphasia. Enabling access to a pervasive mode of communication in today’s digital society may facilitate social connectedness, which is consistent with NIDCD’s mission to improve the lives of individuals living with communication disorders.